University of Montreal Cardiac Surgery Clinical Investigation Group

DESCRIPTION (provided by applicant): The goal of the CTSN is to evaluate CT surgical interventions and related management approaches for the treatment of cardiovascular disease and conditions in adult patients. The network provides support to maintain an infrastructure to develop, coordinate, and conduct multiple collaborative surgical trials designed to improve cardiovascular outcomes and optimize post-operative neurological function. The aim of this research plan is to describe the experience, expertise, collaborative nature and resources of the University of Montreal cardiac surgery Clinical Investigation Group (UMCSCIG) which comprises the Montreal Heart Institute (MHI), Sacre-Coeur Hospital of Montreal (HSC) and The University Center of the Universite de Montreal (CHUM) that will substantially contribute, as in the first cycle of funding of the CTSN, to the success of the cardiothoracic Surgical trials Network. This University of Montreal Cardiac Surgery Clinical Investigation Group renewal application will be separated into three sections: 1) A description of the University of Montreal Cardiac Surgery Clinical Investigation Group; 2) The experience of the MHI, the PI-applicant and of the group investigators; 3) A description of particular characteristics and expertise that the U of Montreal group can bring to the larger NIH network.

Public health relevance
RELEVANCE: Cardiovascular disease (CVD) constitutes a large morbidity and mortality burden in the United States, and consumes a large portion of the health care bill. Cardiothoracic (CT) surgery has been an important therapeutic tool in addressing many of the most prominent cardiovascular conditions, including coronary artery disease, congestive heart failure and valvular disease, among others. CT surgery has been very innovative in addressing these disease challenges. Coronary artery bypass grafting (CABG), cardiac valve repairs, ventricular assist devices, artificial hearts, and arrhythmia surgery have extended survival and improved the quality of life for many patients.